Understanding how experience shapes language development through comparisons of large language models and neural representations

Project Summary
Language experience plays a critical role in language development across childhood. However, in studying
humans, it is difficult to disentangle the effects of language experience from non-linguistic factors that also
change across childhood and adolescence. Recent advances in AI have led to the emergence of large
language models (LLMs), which not only are exceptional at producing language, but also share remarkably
similar representations with the adult human brain. Building on my extensive prior training in cognitive
neuroscience and language development, the proposed research will combine precision functional
neuroimaging and computational modeling to systematically test the role of language experience in the
development of the brain’s language network. Specifically, I will apply model-to-brain similarity approaches that
have been developed in work with adults to characterize developmental changes in how language is
represented by the human brain, and test whether LLMs trained on age-matched amounts of language data
recapitulate developmental shifts in the linguistic representational space. First, I will use functional magnetic
resonance imaging (fMRI) to measure brain responses to a diverse set of sentences in young children (N=12,
ages 6-8), older children (N=12, ages 10-12), adolescents (N=12, ages 14-16), and two groups of adults (N=8,
ages 20-22; and N=8, ages 28-30). Next, I will train an LLM on different amounts of language data,
corresponding to the estimated amount of language experience across the lifetime in each of these age
groups. Finally, I will test the critical hypothesis that representations from an LLM will best align with neural
representations of the corresponding age group. The proposed research will support my fellowship goals of
gaining proficiency in the use of computational modeling, especially LLMs, as a tool in cognitive neuroscience
research, and continuing to develop expertise in state-of-the-art fMRI data collection and analysis methods. An
additional goal during the fellowship period is to develop practical skills to prepare for being a principal
investigator. Dr. Evelina Fedorenko’s lab at MIT, and the department of Brain and Cognitive Sciences more
broadly, is the optimal place to conduct both the proposed research and my postdoctoral training: on a lab-,
department-, and institution-wide scale, there is enthusiasm, expertise, and ample resources to apply AI and
modeling approaches to scientific inquiry. I will take advantage of opportunities within MIT and the greater
Boston area’s academic environment to attend multidisciplinary talks, engage in coursework with experts
particularly in computational tools, and collaborate with other researchers in related fields.

Public health relevance
Project Narrative Children’s experiences with language – such as conversations with peers and adults, reading books, and formal education – are foundational for their socio-linguistic development and life outcomes, but from a research standpoint, these experiences are challenging to precisely characterize or manipulate. Recent advances in artificial intelligence, particularly large language models, provide novel and unprecedented opportunities to examine the role of language experience on the developing brain. The proposed research combines pediatric functional neuroimaging with state-of-the-art computational tools to better understand changes in the brain as language develops throughout childhood and into adulthood.